Administration

PROJECT SUMMARY (See instructions): Core A provides administrative support to the Program as a whole and manages its vibrant external seminar series. Importantly, Core A also provides computational support for the program, particularly by maintaining program databases, by educating program personal in the use of available computational tools, and by developing customized analysis pipelines within the Galaxy environment. Finally, the Core provides access as needed to high-end computational collaborators to address the more exotic informatic problems faced by Program investigators.

Public health relevance
RELEVANCE (See instructions): Core A provides cohesion to the P01 and insures frequent and productive interactions among investigators. The computational support that it provides is also increasingly key to the types of science pursued within the Program.